Spillover Benefits: The Impact of Summer Programming on Parental Rules and Routines Associated with Children's Obesogenic Behaviors

Summer vacation exerts a negative effect on children’s (5-12yrs) obesogenic behaviors (i.e., reduced activity,
increased screen time, poor diet intake, shifted/disrupted sleep); children gain 3-5 times the amount of weight
during the summer compared to the entire school year. The structured days hypothesis posits the structured
environment created by school regulates obesogenic behaviors. During summer, less structure is present,
leading to accelerated weight gain. We hypothesize seasonal changes in children’s obesogenic behaviors may
be due in part to parents relaxing rules/routines related to obesogenic behaviors during the summer. During
summer vacation parents are more lenient with rules/routines, such as allowing children to go to bed later and
use screens more frequently. However, when a child attends a program that occurs at pre-specified days and
times, like school, parents may enforce health-promoting rules/routines (e.g., earlier bedtime, limits on screens).
Because the typical operating hours of summer day camps mimic the structure provided by school, attending
summer day camp may also influence parent health-promoting rules/routines. This would promote greater
consistency of parent health-promoting rules/routines during the summer; similar to rules/routines during the
school year. We hypothesize that attending summer day camp will influence parent health-promoting
rules/routines in the absence of a formal parenting behavior intervention and lead to more healthful behaviors of
children at home. This spillover effect – summer day camp influences parent health-promoting rules/routines at
home – can have important implications for obesity interventions during the summer. This F32 Post-Doctoral
fellowship application will leverage data from a randomized clinical trial (NIDDK R01DK120490, PI Beets)
enrolling 280 elementary-age children from low-income households with half randomized to receive free access
to 8-weeks of community-operated summer day camp. We will quantitatively and qualitatively examine the
impact of providing access to summer day camp on parent rules/routines associated with sleep, screen time,
and diet. Further, we will examine the influence of parent health-promoting rules/routines on objectively
measured obesogenic behaviors and child zBMI. The primary aim is to evaluate the impact of access to summer
day camp on changes in parent health-promoting rules/routines from school to summer compared to a control
group who do not receive free summer day camp. The secondary aim is to evaluate the impact of parent health-
promoting rules/routines on changes in child obesogenic behaviors and weight (zBMI) from the school year to
summer. The final aim is to describe parent perceptions of how/why they maintain/change health-promoting
rules/routines during the summer. This study is significant because it is necessary to understand the mechanisms
by which child obesogenic behaviors shift during the summer. This study will inform future summer childhood
obesity prevention programs. This study is innovative because it is among the first to evaluate the impact of
summer day camp access on parent health-promoting rules/routines within an RCT.

Public health relevance
PROJECT NARRATIVE Elementary aged children exhibit more obesogenic behaviors and accelerated weight gain during summer vacation when they do not attend school; this may be due in part to parents relaxing health-promoting rules/routines during the summer. When children attend summer day camp they engage in more healthy behaviors, fewer obesogenic behaviors, and experience less excess summer weight gain; however, it is unknown if there are spillover benefits where summer day camp influences parent rules/routines related to obesogenic behaviors. Therefore this research and training plan are aligned to evaluate the impact of access to summer day camp on changes in parent rules/routines related to obesogenic behaviors and evaluate the impact of parent health-promoting rules/routines on changes in child obesogenic behaviors and weight (zBMI) from the school year to summer.